Role of neutrophils and eosinophils in bacterial ligand-induced vasculitis

PROJECT ABSTRACT
Kawasaki disease (KD), the leading cause of acquired heart disease among children in the US, is an acute
febrile illness and systemic vasculitis of unknown etiology that causes coronary artery aneurysms (CAA) and can
result in long-term cardiovascular sequelae. While Intravenous immunoglobulin (IVIG) treatment lowers CAA
development to 5%, up to 20% of KD patients are IVIG-resistant and have a greater risk for coronary
inflammation. A better understanding of the immune pathological mechanisms leading to the development of KD
vasculitis is one of the highest research priorities. Recent genetic data, and data from experimental mouse model
of KD, have all converged on the critical role of IL-1 signaling in pathogenesis of the KD lesions. Two clinical
trials using the IL-1R antagonist were recently initiated in KD patients who do not respond to IVIG. Studies
identifying the underlying immune-specific mechanisms involved in IL-1β production are needed and little is
known regarding which immune cell subsets produce IL-1β during KD vasculitis. By using a murine model of KD
vasculitis associated with coronary artery inflammation and abdominal aorta aneurysm development, we found
that inflamed vascular lesions are infiltrated by neutrophils and eosinophils that express high levels of Il1b, Nlrp3
and Padi4 transcripts, the latter one encodes PAD4, a protein known for its crucial role in neutrophils extracellular
traps (NETs) formation. Our preliminary data also demonstrate that PAD4 inhibition blocks not only IL-1β
production in vitro but also prevents LCWE-induced KD vasculitis in vivo, how this blockade directly affect NETs
and eosinophils extracellular traps (EETs) formation and their IL-1β production remain unknown. Our new data
also demonstrate that IL-33 is pathogenic and may promote the pro-inflammatory functions of eosinophils
through the IL-33 receptor, ST2. Therefore, based on our preliminary data, the central hypothesis from this
application is that activated neutrophils and eosinophils promote LCWE-induced KD vasculitis through a
PAD4-dependent release of NETs and EETs, bioactive IL-1β and other pro-inflammatory mediators. Here,
we will investigate the role of eosinophils and neutrophils during murine KD vasculitis and propose interventions
aiming to block IL-1β production by those cells and PAD4 signaling, as well as the disruption of IL-33 signaling
on eosinophils, which may result in decreased inflammation and the prevention of KD lesions. To investigate this
central hypothesis, we propose the following specific aims: 1) Determine the role of infiltrating neutrophils
during LCWE-induced KD vasculitis, 2) Determine the role of tissue-infiltrating eosinophils during
LCWE-induced KD vasculitis and 3)Determine the role of PAD4 in neutrophils and eosinophils during
LCWE-induced KD vasculitis. The successful conclusion of these studies will significantly alter the way KD is
understood and influence the development of new therapies.

Public health relevance
PROJECT NARRATIVE Bacterial ligand-induced murine vasculitis, coronary arteritis and myocarditis is highly dependent of NLRP3 inflammasome activation and bioactive IL-1β release. Here, we will characterize the role of neutrophils and eosinophils infiltrating the inflamed tissues and investigate how the modulation of NLRP3 and PAD4 activity could prevent the vascular innate immune responses leading to vascular inflammation and injury.